Novel Ultrasound Indices of Intracranial Pressure and Brain Ischemia in Neonatal Hydrocephalus

Novel Ultrasound Indices of Intracranial Pressure and Brain Ischemia in Neonatal Hydrocephalus
Project Summary
Neonatal hydrocephalus affects 1-2 of every 1000 live births and results in neurologic deficits in up to 78%
treated patients. A wide spectrum of etiologies including intraventricular hemorrhage, congenital aqueduct
stenosis, myelomeningocele, and brain tumors cause an abnormal accumulation of cerebral spinal fluid (CSF)
in this disease, resulting in cerebral ventricular dilatation and elevated intracranial pressure (ICP). While
ventricular shunting is used as surgical treatment for CSF diversion, the decision to shunt is based on ventricular
size and clinical judgement which are not sensitive markers of ICP and brain health. Thus, delayed diagnosis of
elevated ICP and surgical shunting can result in permanent brain damage and long-term neurologic deficits.
Insertion of invasive ICP monitor is not routinely done due to the associated risk of bleeding and regional brain
ischemia in the vulnerable neonatal brain. In order to provide a solution to a significant gap in clinical care of
neonatal hydrocephalus, we utilize the contrast-enhanced ultrasound (CEUS) technique for noninvasive
detection of ICP and brain ischemia in a well-established porcine model of hydrocephalus. CEUS uses
intravascular injection of microbubbles of average 2-3 µm in size for assessment of tissue perfusion. With the
combined use of the novel particle tracking method (so-called particle intensity and/or tracking velocimetry) and
traditional perfusion analysis, the underlying spatial and temporal changes in cerebral microcirculation can be
quantified for assessment of elevated ICP and brain ischemia. Note that CEUS has been FDA-approved for
pediatric applications in the U.S. as of 2016 for evaluation of focal liver lesions and vesicoureteral reflux, but its
application in neonatal brain is off-label. For this, the PI currently spearheads the first FDA regulated,
Investigational New Drug (IND)-approved clinical trial applying brain CEUS in infants and published the first
imaging guidelines on brain CEUS in infants; the potential for immediate clinical translation of the validated
method following the completion of this proposal is therefore significant. The central hypothesis of the proposal
is that CEUS will be an accurate biomarker of intracranial pressure and brain ischemia. The overall goal of the
proposal is therefore to 1) validate CEUS indices of intracranial pressure and brain ischemia using an already
established infant porcine model of hydrocephalus and to 2) assess in vivo safety of the optimized brain CEUS
protocol. Our work will set the stage for clinical translation of a new noninvasive tool for assessment of intracranial
pressure and brain ischemia in neonatal hydrocephalus, which can ultimately improve the guidance of shunting
and long-term neurologic outcomes.

Public health relevance
Project Narrative Neonates with hydrocephalus are in need of a noninvasive biomarker of intracranial pressure and brain ischemia for timely surgical intervention. The proposal tests a novel imaging approach using contrast-enhanced ultrasound to assess intracranial pressure and brain ischemia in the infant porcine model of hydrocephalus and sets the groundwork for clinical translation.